Advanced Technology QA Core Services Plan

The Advanced Technology QA Core provides the following services and infrastructure: (1) development, implementation, and maintenance of an advanced medical informatics infrastructure which will facilitate: a) collection of clinical trial data from participating sites in standard communication formats, b) automated data integrity, standardization, and completeness verification, and c) long term maintenance of data in a form which will enable remote review and query by investigators involved in projects 1, 2, and 4 of this application. (2) provide a highly configurable environment for automated dose-volume analysis of radiation therapy plans. The environment will enable dose-volume analysis feedback at the point of data submission as well as retrospective data extraction including batch processing of study data. (3) collection, review and dissemination of treatment plans for assessment of treatment plan quality and robustness. (4) common workflow management environment through a secure, highly automated web-based workflow interface for individual participating sites, study investigators and ATC for facilitation of data and task handoffs and for increased compliance and efficiency in data submission and management for projects 1, 2, and 4 of this application. This project supports the mission of the NCI to improve the treatment and continuing care of cancer patients.

Public health relevance
This research aims to improve radiation treatment for cancer patients by improving our ability to direct the radiation at the tumor to spare adjacent normal tissue by using protons (charged particles) with intensitymodulated proton therapy. This can potentially improve cancer cure rates, reduce side effects, or both, depending on the clinical scenario. With an increasing number of proton centers in the United States and abroad, the research in this program project is increasingly important for public health.